Family-building After Cancer: Preferences, Decisions, and Planning for Young Female Survivors

PROJECT SUMMARY/ABSTRACT
Many young adult female (YA-F) cancer survivors (18-39 years old) who received gonadotoxic therapy will
experience fertility problems when trying to build a family and will need to use assisted reproductive technology
(ART) or adoption to have children. However, there are significant informational, psychosocial, and financial
barriers to ART and adoption. Lack of awareness, unrealistic expectations, distress, and avoidance or
postponement of fertility care put YA-F survivors at-risk for being unable to have a child when they are ready or
experiencing greater difficulty, medical or legal complications, distress, and higher costs during the process. To
address this gap, the proposed project will develop and pilot test the first theoretically driven, evidence-based
decision aid and planning tool for family-building after cancer. The interactive, web-based tool will help YA-Fs
become informed, manage negative affect, and plan financially for future costs, thereby addressing key
barriers to family-building after cancer, while inspiring hope that parenthood will be achieved. The study will be
conducted in two phases. In Phase 1, we will develop a decision aid and planning tool using a responsive
design website platform (Aim 1). First, a prototype will be designed based on a self-regulation framework,
extensive pilot data, and with input from a multidisciplinary research team and Patient Research Partners.
Then, we will conduct usability testing (n=10) to iteratively test and modify the prototype for usability,
acceptability, and satisfaction. In Phase 2, we will conduct a single-arm pilot trial to evaluate the feasibility and
acceptability of the tool and study procedures (Aim 2a) and to obtain effect size estimates for a large-scale trial
involving the decision aid and planning tool (Aim 2b). A pre-post study design will be employed with
questionnaire assessments at baseline (T1) and one and three month follow-up time points (T2 and T3). For
Aim 2a, feasibility (rates of eligibility, enrollment, attrition, and reasons for refusal) and acceptability (web
analytics, questionnaire completion rates) will be evaluated. For Aim 2b, effect size estimates will be calculated
for reduction of decision conflict (primary outcome) and completion rate of an “action plan” module (secondary
outcome). Changes in unmet information needs, reproductive concern, and financial capability, and in users’
confidence discussing fertility/family-building with others and motivation to take action will also be explored.
Findings from this study will be used to lay the groundwork for designing an adequately powered efficacy trial
(R01 submission), which Dr. Benedict will be well-prepared to lead after completing her training goals and the
mentorship provided. The proposed career development award will allow Dr. Benedict to become an expert in
digital health communication and technology-based intervention development and analysis within young adult
cancer survivorship research, and support her becoming an independent investigator with R01-level funding.

Public health relevance
PROJECT NARRATIVE Having children after cancer is one of the most distressing concerns of young adult female cancer survivors who complete gonadotoxic treatment, particularly those that may need to use assisted reproductive technology or adoption. Lack of awareness, unrealistic expectations, distress, and avoidance or postponement of fertility care put survivors at-risk for greater complications, potentially losing the opportunity to have a child when they are ready, or experiencing greater difficulty, distress, and higher costs during the process. The proposed study will directly address this public health concern by developing the first patient resource to address fertility and family-building decisions after cancer, thereby ensuring women are prepared and able to having children and build their families in the future.